Fundamental Mechanobiology of Tumor Progression

DESCRIPTION (provided by applicant): This section explains the structure and function of our center Administration Unit, which includes the Center Adviser Committee (CAC), PS-OC Steering Committee (PSC), and ether internal advisory committees that will be formed to ensure effective communications, management, scientific productivity, oversight and evaluation.